A Mightier healthcare system: Introducing a game-based pediatric mental health intervention into payor-sponsored care to evaluate financial and clinical outcomes

PROJECT SUMMARY
Access to effective pediatric mental health treatment is a major public health concern in the United States as
paucity of pediatric providers leading to long wait times, financial burden, and stigma pose significant barriers
to treatment. Digital mental health promises to remedy many chronic problems we face in providing timely and
accessible mental health interventions to children. With that in mind, we created Mightier, an app-based heart
rate biofeedback videogame platform designed to teach and facilitate practice of emotional regulation skills.
Since launching in 2016, Mightier has reached 17,000 families, with a monthly growth rate of approximately
10%, and month to month retention of 90%. The technology behind Mightier is backed by three trials showing
clinical efficacy and since commercial launch 75% of families who have engaged with the product report
improvement. However, our core mission remains increasing access to care, and the direct-to-consumer
distribution of digital health also faces access challenges. We propose that access to effective digital mental
health interventions can be increased by meeting families where they already know to seek care: the traditional
healthcare system. We have partnered with a nationwide behavioral health insurance provider to pilot the
integration of Mightier with traditional healthcare clinics.
The proposed research will pilot the integration of Mightier into the two behavioral health clinics identified by
our payor partner. To simulate real-world integration, healthcare providers will be responsible for referring
children with chronic emotional dysregulation to Mightier. Once identified by their providers, children will be
randomized into Mightier or control groups for 6 months of use. Through this work we will demonstrate the
value of Mightier to various stakeholders via decreased long-term healthcare utilization (aim 1), confirm that
Mightier use results in decreased symptoms of emotional dysregulation, irritability, and parent stress (aim 2).
Ultimately this work will pave the way forward for large scale integration of digital healthcare and more
traditional healthcare avenues while simultaneously increasing Mightier’s ability to reach children in need.

Public health relevance
PROJECT NARRATIVE Integrating in-clinic and in-home digital mental health care has the potential to revolutionize the approach to, and increase access to, outpatient care. Today, outpatient healthcare takes place in offices with little follow up between visits. If digital health interventions like Mightier can be successfully integrated into traditional healthcare settings, families will receive engaging, low-cost interventions that maximize investment in in-office time, leading to better clinical and financial outcomes.